Recipes, menus, and food guidelines for treatment &prevention of hypertension

The purpose of this study is to develop recipes which are tasty and which sound like foods which American families might like to prepare and eat. These foods will be based on the DASH (Dietary Approaches to Stop Hypertension) national blood pressure study. The DASH diet has been found to lower blood pressure. We will examine the results of using this diet in persons with high blood pressure or are at risk for high blood pressure (also called "hypertension"). We will provide meals which include foods to sample that are based on the DASH eating plan. These foods and recipes will be evaluated according to taste preferences and eating habits, with feedback requested on how we can improve them. 15 mealtime sessions will occur at the CRC over a 6 month period. Participants will be members of the "DASH Foods Tasting Panel."